A Tolerance Approach to Xenotransplantation

PROJECT SUMMARY
A major challenge in organ transplantation is the shortage of human organs. The Sykes lab has focused on
investigating and developing new methods for inducing tolerance to prevent graft rejection. A method to address
organ shortages is through the development and increased use of xenotransplantation, such as pig to human
organ transplants. A major barrier of xenotransplantation is the necessity for long-term, high levels of
immunosuppression due to increased polymorphisms compared to human to human organ transplantation.
Although we have demonstrated the ability to achieve human T cell development in pig thymus grafts, we have
also identified defects in positive and negative selection on a pig thymic epithelium of human T cells that must
interact with human APCs in the periphery following transplantation. Our lab has been able to construct a hybrid
porcine thymus that showed improved immunological functions. Thus, the objective of Project 3 in the parent
proposal is to investigate the possibility of tolerance induction in humans through the use of mixed xenogeneic
chimerism and two types of porcine thymic transplantation in HIS mice. Specific AIM #1 of Project 3 of the parent
grant is to achieve optimal tolerance and immune function by combining mixed chimerism with either hybrid
thymic transplantation or pig plus human thymic transplantation. Specific Aim #2 is to determine the mechanisms
of T and B cell tolerance of this mixed chimerism and thymic transplantation in HIS mice. The proposed studies
for this supplement relate to the investigation proposed for Specific Aim #2 of the parent grant, in which we will
determine the mechanisms of T cell tolerance through mixed chimerism and thymic transplantation. This
supplemental proposal aims to develop a method of clarifying the role of Treg mechanisms in xenotolerance.
The supplement focuses on generating and understanding the human anti-pig Treg repertoire and the role of
direct and indirect Treg responses in tolerance modeled by our two approaches in the parent grant. The proposed
studies will establish a clear method for investigating the role of Tregs with direct and indirect specificity in
induced human T cell tolerance to porcine xenografts These studies will also be of considerable relevance to
studies in Project 2, in which expanded baboon Tregs are used to promote mixed chimerism from porcine donors.

Public health relevance
PROJECT NARRATIVE A major issue related to successful transplantation in patients is the shortage of human organs available, in addition to the high levels of immunosuppression necessary to prevent xenograft rejection, without guarantee of success. This need to establish pig-specific tolerance in humans leads to this proposal to investigate the direct and indirect pig-specific human regulatory T cell response. We will identify and characterize the directly pig- reactive human Treg repertoire using healthy control human PBMCs and pig PBMCs, in addition to characterizing the indirectly pig-reactive human Treg response, which will involve the use of human APCs to present pig antigen with healthy control PBMCs.